Clinical Research and Epidemiology in Diabetes and Endocrinology

PROJECT SUMMARY
The Clinical Research and Epidemiology in Diabetes and Endocrinology Training Program at
Johns Hopkins University is applying for its third competitive renewal after completing 15 years of
funding. Our training program at Johns Hopkins, established in 2002, is devoted to clinical and
epidemiologic research in diabetes and endocrinology. Fifteen years later, it remains the only one
of its kind in the US. Thus far, we have successfully trained 36 young scholars (17 pre-docs and
19 post docs) who have produced 128 peer-reviewed scientific papers and who hold research
positions across the country. During the last funding cycle, we trained 4 under-represented
minorities and 13 women. Our program includes 3 pre-doctoral and 2 post-doctoral slots.
Following the untimely deaths of Drs. Saudek and Brancati, former program leaders, Dr. Sherita
Golden, an endocrinologist cross-trained in epidemiology, assumed leadership of the training
program. The new leadership team, supported by an Executive and Advisory Committee,
proposes a fourth cycle of funding with the following specific aims: (1) to recruit a diverse group
of young trainees in endocrinology (post-docs) and epidemiology (pre-docs) from a national pool
of talent attracted to Johns Hopkins; (2) to enroll them in rigorous, thesis-bearing Masters' and
PhD programs in Epidemiology and Clinical Investigation in the Johns Hopkins Bloomberg School
of Public Health; (3) to expose them to a strong team-oriented, multi-disciplinary clinical and
epidemiologic research culture in the Welch Center for Prevention, Epidemiology, and Clinical
Research—the premier educational home for clinical research training at Johns Hopkins; (4) to
guide each trainee to an experienced, NIH-funded mentor who will take responsibility for the
successful completion of a significant thesis project; (5) to expand research training opportunities
in implementation science through the Armstrong Institute for Patient Safety and Quality. To
accomplish these goals, our program brings together faculty and trainees from the Divisions of
Adult and Pediatric Endocrinology and General Internal Medicine (School of Medicine), the
Department of Epidemiology (School of Public Health), the Welch Center for Prevention,
Epidemiology, and Clinical Research, and the School of Nursing. Twenty mentors will serve as
primary faculty and were selected for their expertise, excellence in mentoring, and active NIH
funding. New mentors have been added with expertise in population health, implementation
science, gastroenterology, pediatric obesity, and renal and cancer epidemiology. If our proposal
is successful, then Johns Hopkins will continue to play a major national role in training the next
generation of patient- and population-oriented researchers in diabetes and endocrinology.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT The goal of our program is to play a national role in training the next generation of patient- and population-oriented researchers in diabetes and endocrinology. We will accomplish this through enrolling talented trainees in endocrinology and epidemiology into thesis-bearing Masters' and PhD programs through our School of Public Health and exposing them to a multi-disciplinary clinical and epidemiological research culture supported by experienced, NIH-funded mentors.